Cancer Health Equity Career Development Program

This renewal application for Years 31-35 of the University of Illinois at Chicago’s T32 application is designed to support a scientific environment to prepare the next generation of cancer researchers through cancer educational programming, mentored research training, and career and leadership development for predoctoral and postdoctoral trainees. Over the past 30 years, the University of Illinois at Chicago’s National Cancer Institute (NCI) T32 program has prepared trainees to focus on the transdisciplinary skills needed to address cancer prevention, control, and survivorship.
This renewal application will continue to train and advance cancer educational training and research by supporting pre and postdoctoral trainees to become independent scientists. Since our initial funding under the R25T mechanism in 1992 (transitioned to T32 in 2018), our T32 has received continuous NCI support resulting in a significant contribution to the cancer research workforce. Of the 18 completed predoctoral trainees, 72% went on to postdoctoral fellowships and of the 14 completed postdoctoral trainees, 71 % accepted academic positions
following the training. This renewal application is in response to PA-20-142.
Aim 1. To continue to recruit and train pre and postdoctoral trainees who are dedicated to academic careers in cancer prevention, control, and survivorship.
Aim 2. To continue to provide a rigorous skills training program with a comprehensive curriculum; transdisciplinary seminars; leadership certificate programs; experiential learning with scientific writing; and experiences in basic, clinical, and applied settings.
Aim 3. To prepare trainees to develop, implement, and disseminate independent research by
providing strong mentorship and scientific specialization in cancer prevention, control, and
survivorship.
Aim 4. To continue to provide plans for Instruction in the Responsible Conduct of Research and in Methods for Enhancing Reproducibility in alignment with NIH policies.
Aim 5. To continue to provide ongoing evaluation of our training program to ensure that it is meeting educational, mentored research training, and career and leadership development metrics.

Public health relevance
The National Cancer Institute provides training for predoctoral and postdoctoral trainees that are vital to public health by supporting a workforce focused on cancer prevention, control, and survivorship. The program equips trainees with the education, mentorship and leadership training that provides them with the skills to address cancer-related challenges.